LEIDOS FUNDING TO59, OPTION 3

The objective of this Ebola & Other Infectious Diseases task order is to better understand Ebola and other emerging infectious diseases and to improve medical outcomes for patients afflicted with the same.